In vivo massive parallel reporter assay to analyze the function of cis-regulatory elements and variants implicated in substance use disorders

Project Summary
Substance use disorders (SUD) are highly heritable. Genome-wide association studies (GWAS) have begun to
identify genetic variants associated with SUD, but their functional role remains obscure as most of these variants
lie in non-coding genomic regions, for which it is difficult to infer function. The primary goal of this proposal is to
establish and deploy a massively parallel reporter assay (MPRA) in mouse brains in vivo after chronic exposure
to fentanyl to measure regulatory activity and the effect of opioid addiction-associated human genetic variants.
The MPRA leverages an innovative design (paired-TSS-MPRA) that captures transcription initiation from both
candidate regulatory sequences and a reporter gene promoter, enabling us to probe enhancer transcription and
enhancer function simultaneously at single-nucleotide resolution. This assay will allow us to characterize the
regulatory grammar of elements that are differentially regulated in addiction settings, while also providing a
platform for us to assess the regulatory potential of human GWAS-derived disease-risk variants in vivo. The R21
phase will ensure the rigor and reproducibility of our method by designing and validating an addiction-targeted
paired-TSS-MPRA method in primary neurons and brain tissues of mice. The R33 phase will functionally
characterize regulatory elements and human SUD-related GWAS variants in mice models of chronic fentanyl
exposure (Aim 1) and validate the role of key transcription factors in regulatory mechanisms associated with
fentanyl addiction-like behaviors (Aim 2). This knowledge will enable us to determine the precise mechanisms
by which genetic variants will impact cis-regulatory activity and will provide a conceptual and analytical
framework for studying the functional role of genetic variants associated with SUD.

Public health relevance
Project Narrative The goal of this proposal is to pinpoint causative regulatory variants and their mechanisms of action that contribute to substance use disorders. To reach this goal, this proposal will develop an innovative addiction- targeted massively parallel reporter assay (MPRA) to measure regulatory activity in a mouse model of chronic drug exposure. The successful accomplishment of this proposal will facilitate the prediction, interpretation and characterization of genetic variants associated with substance use disorders.